Leveraging single-cell multi-omics to investigate rare noncoding variants in Parkinson's Disease

PROJECT SUMMARY/ABSTRACT
Parkinson’s disease (PD) is a complex neurodegenerative disorder, with numerous genetic and environmental
features that modify disease risk and progression. While genome-wide association studies (GWAS) have
identified many genetic loci that are associated with PD risk, there is still a large portion of heritability that is
unexplained. This current study highlights the significance of rare noncoding variants, which have been largely
overlooked in previous research that primarily focused on common polymorphisms or rare coding variants, by
characterizing the impact of these variants on gene regulation. I hypothesize that rare noncoding variants play
a substantial functional role in the genetic component of PD by influencing chromatin accessibility and gene
expression in a cell type-specific manner.
We utilize machine learning approaches that learn patterns in cell type-specific chromatin accessibility signals
to identify functional rare noncoding variants in PD patients. We have used these deep learning models to
predict how a noncoding variant may perturb chromatin accessibility, and thus gene regulation. In Aim 1, we
will analyze the impact of ML-nominated candidate noncoding variants on gene regulation using a
comprehensive atlas of matched single-nuclei chromatin accessibility and gene expression data from PD
patients and cognitively healthy control individuals. We will investigate how select rare noncoding variants
affect gene regulation and disease-associated pathways in a cell type-specific manner. In Aim 2, using
massively parallel reporter assays, we will then experimentally validate the functional effects of ML-prioritized
rare noncoding variants and analyze their allelic effects using in vitro models of brain cell types. By comparing
rare and common putative functional noncoding variants, the research aims to understand potential differences
in their mechanisms of action.
This project will fill a critical knowledge gap in the understanding of the genetic basis of PD. By providing
insights into how rare and common noncoding variants influence gene regulation in specific brain cell types,
this research will serve as a valuable roadmap for studying noncoding variants in other heritable diseases as
well. Through this project, I will develop skills in computational and experimental functional genomics
approaches that will allow for meaningful contributions to our understanding of PD, ultimately improve PD
diagnosis and treatment and strengthen my training as an aspiring physician-scientist.

Public health relevance
PROJECT NARRATIVE Parkinson’s disease is a complex neurodegenerative disorder with a large unexplained genetic component and the role of rare noncoding variation remains poorly understood. This research proposal aims to improve our understanding of the genetic architecture of Parkinson’s disease by utilizing deep learning and functional genomic approaches to characterize the impact on putatively functional rare noncoding variants on gene regulation. This project will improve our understanding of noncoding variation found in Parkinson’s disease patients, providing a step towards improved understanding of disease pathogenesis and patient prognostication.